Component A [Core Surveillance] Pregnancy Risk Assessment Monitoring System (PRAMS)

Project Summary/Abstract – Component A (Core Surveillance)
The Colorado Department of Public Health and Environment, in collaboration with the
Centers for Disease Control and Prevention, collects data annually on women who have
recently given birth through the Colorado Pregnancy Risk Assessment Monitoring System
(PRAMS). Data collected in PRAMS include maternal characteristics and behaviors, pregnancy
risk factors, and birth outcomes. These data are generalizable to all live births in Colorado
because they are based on a probability sample and statistically weighted. PRAMS is an
ongoing, population-based surveillance system designed to supplement birth certificate data
and to generate state-specific perinatal health data. Each month, a stratified random sample
comprised of approximately 2.5 percent of Colorado women who recently had a baby are
selected from eligible birth certificates. The sample is stratified by region of residence (Denver
Metro, Other Metro, Rural) to ensure an adequate sample in the rural areas of the state.
Selected women are asked to complete the PRAMS questionnaire by mail or over the
telephone. The questionnaire addresses a variety of health and psychosocial issues such as
prenatal and postpartum care, maternal use of alcohol, cigarettes and marijuana, breastfeeding,
stress, mental health, infant health, and more. Respondents who complete the questionnaire
receive a $20 gift card for participating and are protected under a human subjects research
designation.
PRAMS has gained importance and visibility over the years because it is a key source for
Colorado-specific, population-based data on the prevalence of many health indicators such as
unintended pregnancy, receipt of prenatal and postpartum care, breastfeeding initiation and
duration, contraceptive use, perinatal substance use, and infant health among women delivering
a live birth. These data can be used to identify groups of women and infants at high risk for
health problems, to monitor changes in the health status of pregnant and postpartum women,
and to measure progress towards goals in improving the health of mothers and infants. PRAMS
data are used by state and local Maternal and Child Health programs to plan and evaluate
programs and policies aimed at improving the health of mothers and infants.

Public health relevance
Project Narrative – Component A (Core Surveillance) The Pregnancy Risk Assessment Monitoring System (PRAMS) is a surveillance project of the Centers for Disease Control and Prevention and the Colorado Department of Public Health and Environment. PRAMS collects state-specific, population-based data on maternal attitudes, behaviors, and experiences before, during, and shortly after pregnancy. PRAMS data are used by state and local governments and their stakeholders to plan and evaluate programs and policies aimed at improving the health of mothers and infants.